Alzheimer's Prevention Initiative ADAD Colombia Trial Program

Project Summary/Abstract
When the API Autosomal Dominant Alzheimer's Disease (ADAD) Colombia Trial (NCT01998841) was
announced in 2012, it launched a new era in AD prevention research. The trial led us to identify ~6,000 persons
from the world's largest ADAD kindred, including nearly 1,200 presenilin 1 (PSEN1) E280A mutation carriers,
who are virtually certain to develop AD and become cognitively impaired at 44 (SD ± 5) years of age; establish
the clinical trials, infusion capability, PET, and MRI infrastructure Colombia needed to conduct interventional
studies in the kindred; and introduce precedent setting scientific, ethical, social support, and logistical paradigms
as well as pioneering sample sharing agreements. Moreover, it demonstrated the ability to evaluate an
experimental treatment in a vulnerable population from a developing country in ways that the participants valued,
such that 94% of participants completed the 5-8 year trial. In recent landmark pivotal trials, the Aβ plaque-clearing
antibody (PCA) treatments lecanemab and donanemab were associated with a significant clinical benefit in mildly
impaired late-onset AD (LOAD) patients, with dramatic Aβ PET and plasma pTau reductions, and significant
effects on other Aβ, tau, neurodegenerative, and inflammatory (A/T/N/I) biomarkers. These data provided
compelling support for the role of Aβ aggregates in the development, treatment, and prevention of AD and
support the use of biomarker endpoints that are likely to be associated with a clinical benefit. Here, we propose
to conduct a two-part clinical trial in 200 cognitively unimpaired and mildly impaired PSEN1 mutation carriers
and 40 placebo-treated non-carriers from this remarkable kindred. In Part 1, carriers will receive up to 18 months
of a plaque-clearing antibody (PCA) treatment (exemplar: donanemab), permitting us to compare the magnitude
of Aβ PET and plasma pTau reductions in this ADAD kindred to that observed in trials of the same drug in Aβ+
mildly impaired LOAD patients and cognitively unimpaired older adults. In Part 2, carriers will be randomized to
receive 1) continued PCA treatment, 2) an oral gamma secretase modulator (GSM) treatment (exemplar:
RG6289) with the potential to minimize the re-accumulation of Aβ aggregates in a complementary, potentially
less expensive, and more scalable way, 3) combined PCA/GSM treatment, and 4) placebo treatment for 18
months. This seamless, double-blind, placebo-controlled, double-dummy study of a PCA and a GSM in
cognitively unimpaired and MCI/mild AD PSEN1 E280A mutation carriers will efficiently address a number of key
questions including (1) determining the efficacy of a PCA in reducing brain amyloid levels in ADAD; (2) examining
the relative efficacy of combination treatment following PCA treatment versus PCA monotherapy versus GSM
monotherapy versus placebo to further lower or maintain low brain amyloid levels as well as on downstream
biomarkers; (3) estimating how long placebo-treated mutation carriers remain amyloid negative following PCA-
induced amyloid clearance; (4) providing a foundation for understanding the longer term clinical impact of the
interventions leveraging the Colombian API Registry; and (5) providing invaluable data and samples for the field.

Public health relevance
Project Narrative The proposed project (Alzheimer's Prevention Initiative ADAD Colombia Program) is intended to clarify whether a clinically effective anti-amyloid antibody therapy reduces amyloid plaques and other biomarker evidence of disease progression in mildly impaired and unimpaired persons from the in the world's largest early onset, autosomal dominant Alzheimer's disease (ADAD) kindred to the same extent as it does in independent studies of late onset AD. The study will also characterize and compare the ability of continued antibody treatment, a potentially more accessible oral amyloid production inhibitor, a combination of these drugs or no drug to further decrease measurable plaques and other biological changes; it will provide a foundation to determine whether these treatments slow down, delay, or completely prevent the clinical onset of ADAD in the impaired and unimpaired mutation carriers; and it will provide an shared resource for the scientific community of trial data and samples from all study participants. The study capitalizes on an established late-onset AD-modifying drug and a promising new “gamma-secretase” modulator, and uses the clinical trial infrastructure that we established in Colombia and at Banner Alzheimer's Institute to advance the treatment, secondary prevention, primary prevention, and study of AD.